MODELS OF GENETIC DIFFERENTIATION

The GCRC Informatics Core was used for studies using bacterial models of gene differentiation to help identify functional domains and the structures responsible for them.